GLUCOCORTICOID FAST FEEDBACK REGULATION IN DEPRESSION

This protocol investigates the importance of steroid feedback on CRH release from the hypothalamus and on ACTH release from the anterior pituitary. With an infusion of cortisol, at a time when endogenous CRH drive is high, we found fast feedback effect of cortisol on beta-endorphin and ACTH secretion in normal subjects. Using metyrapone in the late afternoon/evening, we are able to block cortisol secretion with rebound effects on ACTH and beta-endorphine secretion.